Pioneer factor activity in transcription and DNA replication

PROJECT SUMMARY
Shortly after fertilization, a dramatic reprogramming of the genome and transcriptome occurs, enabling the
embryo to develop quickly and robustly. This is especially exemplified in the Drosophila embryo, which within a
two-hour period undergoes 13 mitotic cycles, cellularizes the blastoderm, patterns the body plan, and gets ready
for gastrulation. While the gene networks underlying these processes have been well studied, it is not clear how
they are collectively initiated, a process referred to as zygotic genome activation. Moreover, although it was
observed that DNA replication occurs before transcription, the mechanisms that control this timing are not known.
Previously, we demonstrated that a single factor, Zelda, acts globally to activate early-expressed genes. We
found that Zelda binding to CAGGTAG sites across the genome lowers nucleosome barriers at enhancers,
thereby facilitating the binding of other key transcription factors. Zelda and these other factors are present in
sub-nuclear “hubs” (discrete foci) that were seen to colocalize at enhancers. We aim to use high-resolution
microscopy to investigate the which structural features of Zelda mediate hub formation. In addition, we are
interested in the regulatory mechanisms that control the timing of transcription and DNA replication so that
conflicts between the two processes are avoided. We propose that Zelda plays a dual pioneering role: 1) to open
chromatin for the Origin Recognition Complex to load and subsequent formation of the Pre-replication Complex,
which occludes the transcriptional machinery until origins have fired, and 2) to open newly formed chromatin for
transcription to initiate. Our goal is to first define origins of replication in early embryos, and to characterize
Zelda's role in origin licensing and transcriptional initiation. Our studies will lend into how these two fundamental
processes of DNA replication and transcription are coordinated during genome activation.

Public health relevance
PROJECT NARRATIVE In the first hours of development, the embryo undergoes rapid cycles of DNA replication followed by high-level transcription of sets of genes required for subsequent developmental processes. We will test the hypothesis that pioneer transcription factors like Zelda in Drosophila play a dual role, first to mark origins of DNA replication, then at those same sites, transcriptional activation. Our findings will have broad implications for pioneer factors in coordinating developmental events in more complex organisms.